The Harvard TH Chan School of Public Health Center for Work, Health and Wellbeing

HARVARD CENTER FOR WORK, HEALTH AND WELL-BEING: OVERALL SUMMARY
This renewal of the Harvard T.H. Chan School of Public Health Center for Work, Health, and Well-being
responds to a significant need for understanding of the impact of conditions of work on worker safety,
health, and well-being, and translating research findings into policy and practice. The mission of the Center
is to protect and promote worker safety, health, and well-being through integrated workplace policies,
programs, and practices that foster safe and healthy conditions of work. Building on our systems-level
conceptual model centered on the conditions of work, we will expand our focus on social and health
disparities, deepen our understanding of contributors to work-related well-being and mental health
indicators, and generate and apply research evidence to advance policy and practice recommendations to
improve workplace conditions. We will build on well-established productive partnerships among Harvard,
Boston College, Northeastern University, Mass General Brigham, Boston University, HealthPartners, and
MA Department of Public Health; a new partnership with Massachusetts Institute of Technology; and an
array of regional and national employers and stakeholder groups. Our aims focus on four critical areas:
(1) Research: The Center will expand the scientific evidence base for protecting and promoting worker
safety, health, and well-being through three large and one small research projects, encompassing etilogic,
intervention, and surveillance research across healthcare, warehouses, and construction. The planned
research includes a new focus on older workers and examines factors associated with thriving from work.
(2) Planning and Anticipating Emerging Issues: To accelerate the acquisition and application of research
evidence to inform policy and practice, the Center’s Evaluation & Planning Core will be the locus of overall
scientific leadership activities. The Center includes a new Emerging Issues Program that will enable the
Center to rapidly respond to new research, policy, and capacity-building priorities. (3) Research to Practice
and Capacity Building: The Center will advance adoption and implementation of Total Worker Health®
(TWH) through dissemination of resources, best practices, and capacity-building approaches to improve
conditions of work. The Center will collaborate with stakeholders, dissemination and implementation
partners, and other TWH Centers and affiliates to synthesize key findings and provide guidelines and
recommendations. The Center will prepare the next generation of transdisciplinary TWH researchers and
build capacity for enterprises to implement TWH. (4) Policy: The Center will advance adoption of evidence-
based workplace and public policies that foster supportive conditions of work and protect and promote
worker safety, health, and well-being. The Center’s Policy Working Group will identify research priorities and
opportunities and ensure that research findings are used to guide workplace and public policies.

Public health relevance
HARVARD CENTER FOR WORK, HEALTH AND WELL-BEING: OVERALL PROJECT NARRATIVE The Harvard T.H. Chan School of Public Health Center for Work, Health, and Well-being aims to improve the health, safety, and well-being of working populations by conducting research to identify working conditions that influence worker health outcomes; testing intervention methods to improve these outcomes; and translating this research into best practice and policies. The Center additionally seeks to understand and characterize disparities in workers’ exposures and health outcomes in relation to socioeconomic position, race/ethnicity, and age, in order to guide recommendations to address those disparities. The Center will respond to the need for an evidence base that will inform development and implementation of effective workplace and public policies in promoting and protecting worker safety, health, and well-being.